Career Enhancement Core

CAREER ENHANCEMENT PROGRAM – PROJECT SUMMARY/ABSTRACT
The community of Congenital Disorders of Glycosylation (CDG) has identified genetic and biologic
alterations in 130+ different CDGs with overall incidence of ~>1:100 000. Nevertheless, thirty years
later, we have no disease natural history data, no comprehensive patient registry, no reliable
screening for many CDG types, and almost no therapy. More importantly, awareness for this ultra-
rare group of inborn errors of metabolism is desirable in clinical practice to relieve the burden of
disease from our patients and their families. A greater number of superbly trained new CDG
clinicians and biochemists are desperately needed. This is the challenge presented by our
patients.
The Frontiers in Congenital Disorders of Glycosylation (FCDG) Consortium in close
collaboration with the patient advocacy group of CDG-CARE (CDG-Community Alliance and
Resource Exchange) expresses its strong commitment to contribute knowledgeable and well-
trained medical professionals (c.q. clinical experts, dieticians) and investigators experienced in
multidisciplinary clinical care and research in, and informed of the public health importance of,
CDGs. A critical part of this process is to increase the quality and depth of clinical and
biochemical experts in CDG. The FCDG CEC's premise is that such medical professionals and
clinical investigators will advance and significantly impact the overall quality of life and health of
children, youth and adults with CDG. An equally critical benefit of this process will be to
increase in the number of CDG research scientists and biochemists moving the field of CDG
research and diagnostics forward from its current state.
To meet this objective, the FCDG CEC will comprise the following components: 1) a stringent
candidate selection system; 2) prescribed training and education to facilitate life-long learning;
3) comprehensive guidance by a group of clinical and biochemical experts with extensive
experience as mentors; d) facilitate collaboration with clinical experts and investigators within
the consortium; and e) a strong commitment to the recruitment of qualified minority individuals,
women, and persons with disabilities into our educational programs.
A Center for Individualized Medicine (CIM), Departments of Laboratory Medicine and
Pathology (DLMP) and Clinical Genomics with the support of the Center for Clinical and
Translational Science (CCaTS) as well as the Office of Research Postgraduate Affairs (ORPA)
at Mayo clinic strengthened by the comprehensive educational and training programs at our
consortium sites will provide institutional infrastructures to all NIH-funded training and
education mechanisms including this CEC. Thus, each FCDG CEC awardee can capitalize on
numerous, relevant strengths present within the Consortium.
Outstanding applicants will be aggressively recruited with efforts especially directed toward
identifying individuals from underrepresented populations. The Mayo Clinic Office for of
Diversity and Inclusion (ODI) will be fully engaged. Each project year, the FCDG CEC will
provide up to $50,000 for one year ($25,000 from SPORE funds and a matching $25,000 from
CIM and DLMP) for each of two awards. A second year of support is possible, based on
progress. Ideally, the proposed training or educational program will embody important “growth”
areas within CDGs and for the overall FCDG Consortium goals. This mechanism will allow us
to allow us to identify, mentor, and support young medical professionals as well as biochemical
geneticists who will become future leaders in CDG care and research. Dr Tamas Kozicz will
act as FCDG CEC director.